Indiana Clinical and Translational Sciences Institute

PROJECT SUMMARY/ABSTRACT
The Indiana Clinical and Translational Sciences Institute (Indiana CTSI) was created in 2008 as a statewide
partnership to accelerate clinical and translational research by the three research universities, Indiana, Purdue
and Notre Dame, with partner health care systems and providers, community and patient stakeholders, local
foundations, corporate and government partners. The mission of the Indiana CTSI is to bring together Indiana's
brightest minds to solve the most pressing health challenges by serving as the statewide catalyst for clinical and
translational research and improve human health across Indiana, the nation and beyond. The Indiana CTSI
fosters a collaborative research environment, provides resources and services to conduct the highest-quality
clinical and translational research, offers education and training programs to build a robust translational
workforce, engages our community as a partner at all levels, identifies and removes barriers to research through
translational science approaches, and functions as an exemplary member of the national CTSA network. The
CTSI plans to accomplish its mission through five Specific Aims: Aim 1. Accelerate training and research
opportunities across the state to create a diverse and trusted translational research workforce that demonstrates
respect, responsibility, and cultural humility through effective communication, team science and authentic
stakeholder engagement. Aim 2. Enrich and integrate our network of patient, health care, corporate, community,
and government agency partners to better engage and empower underserved populations across Indiana,
focusing on regions and groups with poorest health outcomes. Aim 3. Enhance access to I-CTSI programs and
services to facilitate and expedite impactful clinical and translational research that is innovative, inclusive,
collaborative, and ethical, and effectively disseminates and implements evidence-based interventions across the
state. Aim 4. Identify barriers, create solutions, and disseminate novel approaches for best practices of clinical
and translational science through community and stakeholder engagement, pilot funding, and a trustworthy and
integrated translational research ecosystem. Aim 5. Leverage our statewide informatics platform and innovative
analytic capabilities to harmonize disparate data sources in collaboration with health systems across the state
and with deliberate inclusion from diverse populations to advance health equity. In 2030, at the end of this seven-
year renewal funding period, we envision the I-CTSI will transform our statewide research ecosystem with
deliberate attention to diversity and inclusion in our partnerships, workforce development and research
engagement. We will accelerate innovation and rapidly implement evidence into practice in order to advance
health equity.

Public health relevance
PROJECT NARRATIVE The Indiana Clinical Translational Science Institute is a partnership among Indiana's three research-intensive universities, Indiana University, Purdue University, and the University of Notre Dame, and the Regenstrief Institute, and has a distinguished history of documented success and a robust statewide research, educational, and community infrastructure on which to build its expansion in this new CTSA funding period. We will transform our statewide research ecosystem with deliberate attention to diversity and inclusion and the principles of trustworthiness and community engagement in our partnerships, workforce development and research engagement. We will accelerate innovation and rapidly implement evidence into practice in order to advance health equity.